Targeting nutrient microenvironment imprinted therapy resistance in pancreatic cancer

PROJECT SUMMARY/ABSTRACT
A major hurdle in the clinical management of pancreatic adenocarcinomas (PDAC) is the profound resistance to
chemotherapeutics exhibited by these tumors. PDAC chemoresistance is mediated by the tumor
microenvironment (TME) as isolated PDAC cells cultured ex vivo readily respond to therapies while PDAC cells
in tumors do not. Thus, identifying the TME factors and mechanisms by which the TME regulates drug response
in PDAC is critical to being able to effectively treat this disease. Towards the goal of identifying TME factors
regulating PDAC biology, we have taken the strategy of measuring physiological parameters in the PDAC TME
and recreating these conditions ex vivo to study in mechanistic detail how PDAC cells are impacted by TME
physiology. As part of this approach, we recently developed techniques to isolate interstitial fluid (the local
perfusate) from PDAC tumors and quantitative metabolite profiling techniques to measure availability of ~150
major nutrients in the PDAC TME. This provided us with the first quantitative atlas of nutrient availability in PDAC
and we found that local nutrient abundance in these tumors was strikingly different than in the bulk circulation or
healthy tissues. To study how abnormal access to nutrients in the TME could impact PDAC cells, we developed
a novel cell culture model in which PDAC cells are cultured with the precise levels of ~120 major vitamins and
nutrients they encounter in the native TME. Using this model, we found that PDAC cells exposed to TME nutrition
exhibit resistance to a wide array of clinically used chemotherapies, identifying abnormal tumor nutrient
availability as a critical TME factor mediating chemoresistance in this disease. Further analysis of TME nutrient-
induced chemoresistant phenotype indicated that: (1) increased availability of the amino acid glycine in the TME
causes PDAC cells to become highly chemoresistance and (2) TME glycine does not endow PDAC cells with
the ability to evade action of chemotherapies, but rather the ability to tolerate damage induced by therapeutic
challenges. Based on these preliminary studies, we developed the hypothesis that TME glycine impairs the
ability of PDAC cells to undergo cell death in response to chemotherapeutic insult, thus enabling PDAC cells to
tolerate chemotherapeutic treatment. In this proposal, we will determine: (1) the metabolic basis for how glycine
accumulates in the PDAC TME and if targeting TME glycine availability can sensitize PDAC tumors to
chemotherapy and (2) the mechanism by which PDAC cells gain tolerance to chemotherapeutic stress and if
targeting these tolerance mechanisms can synergize with chemotherapy. Therapy resistance is a major
contributor to the poor prognosis of PDAC patients. Our work addresses this key therapeutic challenge in a
disease with much unmet clinical need and could identify novel therapeutic options for PDAC patients.

Public health relevance
PROJECT NARRATIVE The tumor microenvironment of pancreatic adenocarcinomas endows these tumors with profound resistance to chemotherapies, which severely hinders clinical management of this disease. We have found that nutrient availability in pancreatic tumors is a key microenvironmental factor that leads to this therapy resistance. In this proposal, we will determine the molecular mechanisms by which tumor nutrition imparts therapy resistance upon pancreatic cancer cells, and if manipulating tumor nutrition and its impact on pancreatic cancer cells can sensitize pancreatic tumors to chemotherapies, which may lead to new therapeutic approaches in this disease.